Applying spatial transcriptomics and mouse molecular genetics to understand the mechanisms of fibrotic scarring for promoting neural repair after spinal cord injury

PROJECT SUMMARY
Spinal cord injury (SCI) is a neurological condition that induces a wide array of transcriptional and functional
changes to a variety of cell types in the central nervous system (CNS), including fibroblasts. After SCI, fibroblasts
undergo a wound healing response called fibrotic scarring, in which they activate, proliferate, and migrate to the
lesion site to produce extracellular matrix proteins. While acute fibrotic scarring is critical in orchestrating tissue
repair and preserving tissue integrity; aberrant, chronic fibrotic scarring, has been implicated to contribute to the
CNS limited regenerative potential after SCI. Chronic fibrotic scarring remains poorly understudied in elucidating
the cellular mechanisms that govern its development, formation, extracellular influence. Transforming growth
factor beta (TGF-β) has been extensively characterized as the central regulator of fibrotic scarring in the liver,
heart, lung, and kidney while also being implicated in the CNS through sc-RNAseq and pharmacological
evidence. However. there is no genetic, cell-specific evidence establishing the role of TGF-β and chronic fibrotic
scarring after SCI and how the fibrotic scar shapes the injury site. This proposal aims to determine the
contribution of TGF-β signaling in chronic fibrotic scarring and its role on the extracellular
microenvironment using mice transgenic models and spatial transcriptomics.
My overall hypothesis is that fibrotic scarring is modulated by TGF-β signaling and contributes
to a nonpermissive microenvironment for neural repair and recovery after SCI. To test this hypothesis, I
will conditionally delete TGF-β receptor 2 (TGFBR2) specifically in fibroblasts using a collagen type 1 alpha 2
promoter and assess fibrotic scarring in mouse models of SCI. Aim 1 will be focused on determining if fibrotic
scarring is driven by TGF-β signaling in fibroblasts following SCI and its impact on hindlimb functional recovery.
Recovery will be assessed in three locomotor behavioral assays. Aim 2 will leverage spatial transcriptomics to
examine the impact of fibrotic scarring attenuation on various spatially resolved injury site cell populations,
structures, and the overall microenvironment. Impacts on the genetic signatures of astrocytes, macrophages,
and microglia will be of specific interest due to their role in neuroinflammation and neurotoxicity after SCI. Aim 3
will focus on manipulating fibrotic scarring to promote corticospinal tract axon regeneration after a dorsal
hemisection SCI. This work will provide better insight into the cellular and molecular processes involved in fibrotic
scarring after SCI, which will lead to more effective therapeutic interventions for spinal cord injury in the future.

Public health relevance
PROJECT NARRATIVE Following injury to the central nervous system, fibroblasts undergo drastic transcriptomic and morphological changes to preserve tissue integrity and limit secondary damage in a process termed fibrotic scarring. However, chronic fibrotic scarring has negative effects on CNS repair. This research proposal aims to utilize mouse genetics, behavioral assays, and spatial transcriptomics to investigate fibrotic scarring in the spinal cord and elucidate its impact on recovery and repair processes following spinal cord injury.